ROLE OF CYTOKINES IN B CELL IMMUNITY AND HEMATOPOESIS

This laboratory has been focusing its efforts on the role of lymphokines and cytokines in hematopoiesis and immune system development. Specifically, we have focused on 1) the biochemical characterization of a lymphokine produced by T cells which stimulates B cells to proliferate and 2) the role of specific lymphokines (i.e. IL 1, CSFs) and cytokines (i.e. TNF) in the protection of bone marrow from lethal doses of irradiation. A high molecular weight lymphokine produced by lectin stimulated T lymphocytes that stimulates B cell proliferation has been characterized and highly purified. This BCGF was free of interleukin 1 and 2 (IL 1 and 2) activities, but could induce B cells to proliferate and to express receptors for IL 2. This lymphokine could also support the growth of BCL 1 cells, a unique property of BCGF-II and could augment the proliferation of a large granular lymphocyte line (YT), several EBV +B cell lines and murine thymocytes. In collaboration with scientists at AFRRI we have demonstrated that in vivo administration of recombinant IL 1 beta or IL 1 alpha, 20 hrs prior to lethal doses of irradiation, is protective. Mice pretreated with IL 1 do show a partial recovery in the number of nucleated bone marrow cells and show evidence of increased erythropoiesis by colony forming assays (CFU-E), whereas there is no such recovery in untreated control mice. Bone marrow from IL 1 treated mice demonstrated increased proliferation when subquently cultured for 3 days with GM-CSF. In contrast, administration of several recombinant lymphokines that are induced by IL 1, namely GM-CSF, IL 2 and immune interferon, 20 hrs and 3 hrs before irradiation had no protective or proliferative effect. Prostaglandins are also not effective. Although neither G-CSF nor CM-CSF were effective by themselves, these CSF's in combination with suboptimal doses of IL 1 had synergistic radioprotective effects. Finally TNF, although not as potent as IL 1, also was observed to be radioprotective by itself. IL 1 and TNF together yielded additive effects, suggesting that their mechanism of radioprotection differs.